Massachusetts Alzheimer's Disease Research Center (MADRC)

Our patients, and the needs of the science, demand that we try to answer the difficult question, “what will
happen to me?”. In this renewal application of MADRC, an interdisciplinary Center for the study of Alzheimer’s
and related dementias at Massachusetts General Hospital, Harvard Medical School, we will build on promising
scientific advances to contribute to answering this question. We propose 7 Cores (Administrative, Clinical,
Biomarker, Imaging, Neuropathology, Data, and Outreach) and a Research Education Component (REC).
Each Core has two major strategic goals: 1) to bring to bear each Core’s unique expertise to understand the
drivers of clinical progression in “normal” aging, Alzheimer’s Disease (AD), Lewy Body Disease (LBD), and
Frontotemporal Dementia (FTLD), and 2) to develop strategies and technologies to improve precision of
measuring pace of progression of both clinical symptoms and underlying disease processes. Our Research
Cohort, which has been rebuilt with a renewed commitment to priority populations, is a state-of-the-art clinical
phenotyping laboratory that will allow us to measure multiple aspects of pace of clinical progression across a
spectrum from normal cognition to mild dementia. We will, for example, develop digital phenotyping and
explore strategies to “take the research to the participant” to break down barriers and improve measurements.
The Biomarker Core uses single molecule detection (simoa) and other technologies focused on analytes
present in plasma that reflect brain pathologies, including tau, amyloid β, inflammation markers, and, in work
we are very excited about, synaptic loss. Our Imaging Core will, for the first time, be resourced to perform
longitudinal MRI and PET scans on the Research Cohort and will explore the use of novel MRI techniques that
promise additional precision. The Neuropath Core is building a set of matched brain/iPS cell pairs from
individuals with different (often mixed) etiologies of dementia and provided them to NCRAD to facilitate studies
of how disease related phenotypes measured in iPS cells relate to neuropathological changes in the brain, and
to clinical change. The Data Core has led major new “Big Data” initiatives and is the analytical engine of the
Center. The ORE Core brings to bear modern behavioral and community engaged research to our group. It
takes the lead in recruitment of a diverse cohort for MADRC studies, clinical trials, and other affiliated
programs, and in building effective networks of communication with the community and with health care
professionals in our eco-system. As a team, we will be able to explore potential drivers of clinical progression
comparing with markers of disease progression (eg amyloid and tau), neuroinflammation, vascular lesions and
neurodegeneration, appreciating that most of our participants will have multiple drivers of cognitive change,
and aware that these relationships may differ in different populations. Finally, education and training of the
next generation of clinicians and scientists is the mission of the REC, and an important component of each
Core. Working together, we hope to make a difference in these devastating diseases.

Public health relevance
Overall: Project Narrative The MADRC is a Center based at Massachusetts General Hospital, Harvard Medical School, devoted to understanding and ultimately contributing to the cure of Alzheimer’s disease and Related Disorders (ADRD). We support research in tracking the course of several hundred participants with an emphasis on diversity, obtain imaging studies and biofluids to develop biomarkers, and request permission for autopsy. The Center supports both clinical and basic science research, and also is a training environment for scientists and clinician-investigators to “build the future”.